Project 1 - TBD

Abstract/Summary
Estradiol (17βE), the primary female sex hormone used as supplementation therapy in post-menopausal aged
women fails to improve cognitive function and is well known to increase the risk of stroke (ischemic reperfusion
(IR) injury). Therefore, it is essential to understand cerebral vascular mechanisms in post-menopausal
conditions to identify 17βE pathways that do not have adverse effects. Cerebral vessels exhibit myogenic
reactivity, a property in which vessels contract with an increase in lumen pressure to maintain a constant CBF.
This essential physiological function is mediated by the dynamic regulation of Ca2+-sensitive large-conductance
K+ ion channel (BK). While BKα-subunit forms a pore, β1-subunit regulates BK channel function. Loss of BKβ1-
subunit function exaggerates myogenic response and vice versa. Recently, studies from our lab suggest that
middle cerebral arteries (MCA) isolated from ovariectomized (OVX) rats exhibit exaggerated myogenic reactivity
and decreased vasodilation due to the downregulation of BKβ1-subunit. However, the mechanism contributing
to BKβ1 downregulation is not known, nor is the exact role of 17βE-mediated regulation of BKβ1. While the
mechanism is suspected to occur via the Nrf2 (transcription factor) antioxidant pathway, more mechanistic study
is needed. Based on this gap in knowledge, the central hypothesis is that “a decrease in 17βE-Nrf2- mediated
transcriptome downregulates BKβ1-mediated vasodilation which increases susceptibility to ischemic reperfusion
injury and results in vascular cognitive impairment.” Preliminary studies have shown that pharmacological
inhibition and genetic deletion of Nrf2 in knock out (KO) rats disrupted 17βE-mediated up-regulation of BKβ1
and pharmacological activation of Nrf2 improved cognitive function in OVX rats. Nrf2KO rats also showed greater
ischemic reperfusion (IR) induced infarct compared to control rats. Therefore, in aim 1, we will test the hypothesis
that "the Nrf2 antioxidant pathway plays a role in BKβ1 vasodilation". In aim 2, we will test the hypothesis that
“loss of 17βE downregulates Nrf2, decreases BKβ1-mediated vasodilation resulting in cognitive impairment”.
Finally, aim 3, we will test the hypothesis that “loss of 17βE-Nrf2-BKβ1-mediated vasodilation exaggerates IR
injury”. Together these studies will identify therapeutic targets to improve cognitive function in post-menopausal
aged women and identify vascular mechanisms involved in cognitive impairment. The expertise and resources
offered through the MCHD-COBRE will allow for a systematic evaluation of the Nrf2-BKβ1 pathway through
acquiring genomic datasets, development and study of gene-edited cell-lines for mechanistic study of Nrf2, and
validation through targeted proteomic analysis, to ultimately provide a molecular to whole animal understanding
of the 17βE-Nrf2-BKβ1-pathway in vascular function.

Public health relevance
Narrative Currently, there is a lack of knowledge of sex-specific mechanisms in menopause-related cerebrovascular dysfunction and vascular cognitive impairment. This proposal attempts to understand and intervene in sex-specific mechanisms to reduce cerebrovascular dysfunction in post-menopausal old females.